Novel Biomedical Imaging Systems for Diagnosing Hearing Loss

Age-related hearing loss (ARHL) is the predominant sensory disorder and neurodegenerative condition of our
aged population. Currently, it is difficult or impossible to diagnose the exact etiology of ARHL, or other types of
hearing loss in a particular patient clinically. This makes effective medical interventions for hearing loss quite
challenging now, and indeed, there are no FDA-approved medical treatments to prevent or treat sensorineural
hearing loss. The endocochlear potential (EP), also known as the “cochlear battery”, is the voltage difference
between the endolymph of scala media and the surrounding fluids of the other two cochlear scalae. The EP
results from the high K+ and low Na+ concentrations in the endolymph due to movement of K ions up a voltage
and concentration gradient by specialized cells of the stria vascularis of the cochlear lateral wall. This voltage
difference is critical for normal functioning of the inner ear, and good hearing. There are reports from animal
model studies demonstrating the significance of the EP for hearing, and how it declines in the aging cochlea,
with downstream effects on other cochlear pathologies as well. However, for human diagnoses, there is no
clinical method available for EP measurements. Post-mortem EP measurements in human cadavers, for
research purposes, are also not feasible, as mammals lose the EP immediately after they die. Currently, a
surgical approach for rodents – exposing the bulla and cochlea, and measuring the EP using a microelectrode,
is the gold standard for EP measurement in animal models. However, this approach cannot be utilized in
humans due to its invasive characteristics, causing both permanent loss of hearing and surrounding tissue
damage, while also being terminal in nature for rodents. This complication makes longitudinal human studies
impossible, thus, hindering the firm establishment of strial atrophy and EP reduction as a predominant clinical
risk factor in ARHL and other types of hearing impairment. Therefore, there is a compelling need to develop an
in vivo, wireless EP measurement technique that could be utilized for human subjects. The primary aim of this
project is to develop a dependable EP measurement methodology using current nuclear and molecular
imaging methods in which a dilute radiotracer can be used to characterize K+ activity within the inner ear. The
proposed research has a unique potential to revolutionize the diagnostic and treatment possibilities for hearing
loss clinically. We combine biomedical engineering and imaging, with hearing sciences, animal model
techniques and neuroengineering to achieve this translational breakthrough for hearing impaired persons.

Public health relevance
The number one neurodegenerative and sensory disorder of the elderly is age-related hearing loss (ARHL), where there are no FDA-approved medical treatments, since its biological mechanisms remain elusive, and analytical techniques needed to clinically diagnose auditory pathologies are still lacking. One such auditory pathology relates to the noticeable decline of a critical part of the inner ear: the “cochlear battery”, commonly known as the endocochlear potential, and is considered as a predominant mechanism of ARHL and other types of hearing loss. The thematic focus of this proposal is to develop an innovative and non-invasive method to measure the “cochlear battery” clinically, to serve as guidance into future targeted therapeutic interventions, both technological and medicinal in nature.